Translational Diebetes Prevention in GDM

DESCRIPTION (provided by applicant): Type 2 diabetes (T2DM) develops in 50% of women with gestational diabetes (GDM) within 5 years after delivery. So far, no lifestyle interventions have been translated for use in women with GDM during the early postpartum period. The screening for GDM practiced in the health system presents a highly efficient identification of a population at high risk of T2DM. The primary aim of the study is to implement and evaluate a diet and physical activity (PA) intervention tailored to postpartum mothers and feasible for a health plan setting, with the primary goals of: a) reaching pre-pregnancy weight if women had a normal pre-pregnancy weight; or b) achieving a 5% reduction from pre-pregnancy weight if overweight or obese before pregnancy. The primary outcomes are the proportion of women who reach their postpartum body weight goal and the total amount of weight change. Secondary outcomes are plasma glucose levels, percent calories from fat, total calories and time spent in PA. Participants will be from a large population (66% from ethinic minority groups) receiving medical care at Kaiser. Women will be randomly assigned to lifestyle intervention or usual medical care (175 in each arm). The interventionists will be dieticians trained in social cognitive strategies and motivational interviewing techniques and located at the Kaiser Perinatal Service Center. The intervention will be delivered via individual telephone contacts and brief in-person counseling sessions augmented with e-mails and a website. Goals for the intervention during pregnancy (Phase I) are to help women comply with the IOM guidelines for weight gain. Phase I will be delivered through 1 individual in-person session and 2 telephone counseling contacts. Phase II begins at 6-weeks postpartum and will be delivered through 2 individual in- person sessions and 10 telephone counseling contacts over a period of 4 months, after which Phase III (maintenance) will begin and participants will receive 9 tailored diet and PA reminders until 24-months postpartum. Intervention women will also be taught about their diabetes risk and how to prevent it. Measurements will be collected at study entry and at 6-wks, 6-m, 12-m, 18-m and 24-m postpartum. Data analyses will be by intent-to-treat. Tertiary aims address psychosocial modeling, within trial cost-effectiveness analysis and evaluation of the intervention for possible adoption. A finding that this intervention is cost-effective in this setting should motivate changes in the health system that would facilitate its adoption.

Public health relevance
PUBLIC HEALTH RELEVANCE: Gestational diabetes is defined as abnormal glucose metabolism during pregnancy. Type 2 diabetes develops in 50% of women with gestational diabetes (GDM) within 5 years after delivery. Although randomized trials have shown that weight reduction by diet and physical activity reduces the risk of type 2 diabetes in older adults, no lifestyle interventions have been translated for use in pregnant and early postpartum women with GDM. The primary aim of the study is to implement and evaluate among women with GDM an intervention of diet and physical activity that starts during pregnancy and continues after pregnancy with the primary goals of a) reaching prepregnancy weight if women had normal weight prior to pregnancy; or b) reaching a 5% reduction of the prepregnancy body weight if women were overweight or obese prior to pregnancy. Targets for the intervention during pregnancy (Phase I) are to help women comply with the Institute of Medicine guidelines for pregnancy weight gain. Phase I will be delivered through 1 individual in-person session and 2 telephone counseling contacts. After pregnancy (Phase II), starting from 6 weeks postpartum, targets for the intervention are to help women reach their postpartum weight goals. Phase II will be delivered through 2 in-person sessions and 10 telephone counseling contacts and will end at 5-6 months postpartum. The maintenance period (Phase III) begins soon after Phase II ends and it will end at 24 months postpartum and will include 9 mailed tailored reminders. If this translational intervention is found to be cost-effective in this setting it should motivate changes to the health care system that would facilitate adoption of the program for all women with GDM. PROJECT NARRATIVE Gestational diabetes is defined as abnormal glucose metabolism during pregnancy. Type 2 diabetes develops in 50% of women with gestational diabetes (GDM) within 5 years after delivery. Although randomized trials have shown that weight reduction by diet and physical activity reduces the risk of type 2 diabetes in older adults, no lifestyle interventions have been translated for use in pregnant and early postpartum women with GDM. The primary aim of the study is to implement and evaluate among women with GDM an intervention of diet and physical activity that starts during pregnancy and continues after pregnancy with the primary goals of a) reaching prepregnancy weight if women had normal weight prior to pregnancy; or b) reaching a 5% reduction of the prepregnancy body weight if women were overweight or obese prior to pregnancy. Targets for the intervention during pregnancy (Phase I) are to help women comply with the Institute of Medicine guidelines for pregnancy weight gain. Phase I will be delivered through 1 individual in-person session and 2 telephone counseling contacts. After pregnancy (Phase II), starting from 6 weeks postpartum, targets for the intervention are to help women reach their postpartum weight goals. Phase II will be delivered through 2 in-person sessions and 10 telephone counseling contacts and will end at 5-6 months postpartum. The maintenance period (Phase III) begins soon after Phase II ends and it will end at 24 months postpartum and will include 9 mailed tailored reminders. If this translational intervention is found to be cost-effective in this setting it should motivate changes to the health care system that would facilitate adoption of the program for all women with GDM. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS In 2006, our third (R18) submission proposing a lifestyle intervention similar to the Diabetes Prevention Program (DPP) but delivered by telephone counseling to women with GDM was judged excellent, but did not reach the pay line. To address the reviewers' concerns regarding the absence of feasibility data, the NIDDK funded the R18 as a feasibility study. Preliminary results from the feasibility study named Diet, Exercise and Breastfeeding Intervention (DEBI) demonstrate the translational aspects of the program: a high proportion of women agreed to participate (40% of all those eligible) and participants were highly representative, 82% of participants were from minority race/ethnic groups and 45% had 2 or more children. The retention rate was high: 94% at 6-weeks and 82% at 12-months postpartum. Women in the intervention group were significantly more likely to lose more weight and to reach the postpartum weight goal than controls. On average, women completed 10 postpartum sessions and 98% reported satisfaction with the intervention. These encouraging results prompted us to propose a lifestyle intervention among a larger sample of GDM women to test its effectiveness in the health care setting. The lifestyle intervention we propose is a modification of the DPP. The proposed modifications result from what we learned from the DEBI feasibility study. The proposed intervention is tailored to pregnant and postpartum women with GDM and is designed to reduce risk factors for type 2 diabetes (T2DM). It will start during pregnancy, soon after a diagnosis of GDM, and continue for 2 years postpartum. It will be delivered via individual telephone contacts and brief in-person counseling sessions using lifestyle coaches trained in social cognitive strategies and motivational interviewing techniques to achieve behavioral changes. Telephone counseling will be augmented with e-mails and an interactive study- specific Web site, to provide individually tailored information. Participants will be randomly assigned to a lifestyle intervention or usual medical care (175 women in each group). Targets for intervention during pregnancy (Prenatal Phase I) are to help women with GDM manage their pregnancy weight gain by complying with current recommendations for diet and physical activity (PA). The Early Post-partum Phase II begins at 6- weeks postpartum and will be delivered through 2 individual in-person sessions and 10 telephone counseling contacts over a period of 4 months, after which the maintenance phase (Late Post-partum Phase III) will begin. In the maintenance phase participants will receive 9 tailored diet and PA reminders in the mail or by e-mail up to 24-months postpartum. Measurements will be at the study entry and at 6-weeks, 6-months, 12-months, 18- months and 24-months postpartum. A. PRIMARY AIM. Among women with GDM, we propose implementing and evaluating a diet and physical activity intervention similar to the DPP, but tailored to postpartum mothers and feasible for a health plan setting, with the primary goals of: a) reaching pre-pregnancy weight if women had a normal pre-pregnancy weight; or b) achieving a 5% reduction from pre-pregnancy weight if overweight or obese prior to pregnancy. Hypothesis A.1. Among women with GDM, a diet and PA intervention that starts during pregnancy and continues postpartum will result in more postpartum weight loss compared to usual care. Primary outcomes will be the proportion of women who reach their postpartum body weight goal and the total amount of weight change (in kilograms). B. SECONDARY AIMS. 1) To assess whether women assigned to the lifestyle intervention will have lower postpartum fasting and 2- hour plasma glucose concentrations than women assigned to usual medical care. Hypothesis B.1. A diet and PA intervention will be associated with lower plasma glucose levels. 2) To compare postpartum changes in percent of calories from fat and changes in total daily calorie intake and PA levels between women assigned to the intervention and those assigned to usual care. Hypothesis B.2. Women in the lifestyle intervention will have greater reductions in dietary fat and total daily calorie intake and a greater increase in PA than women assigned to usual medical care. Secondary outcomes will be fasting and 2-hour plasma glucose (measured after a 75-g oral glucose load), percent of calories from fat, total daily calorie intake and time spent in PA, by intensity of activity. C. TERTIARY AIMS. 1) To determine whether the effectiveness of the intervention differs according to the women's characteristics (i.e., demographic, psychosocial, and clinical factors). 2) To assess whether changes in stage of change, knowledge of diabetes risk, and self-efficacy predict postpartum outcomes (i.e., weight, glycemia, dietary fat, and PA). 3) To determine the within trial cost-effectiveness of the lifestyle intervention. 4) To evaluate the intervention, its implementation, and potential adoption into KP standard care. D. TRANSLATION. Women with GDM represent a population at high risk for T2DM and are identified by the health care system at a very young age, due to standards of care that include screening for GDM. Ordinarily, the major cost of translating the DPP would be identifying the at risk population. The integrated KP clinical setting greatly facilitates identifying patients and implementing this program with them. The laboratory databases allow "real-time" identification of newly diagnosed women with GDM, saving time and resources that would otherwise be spent identifying the target population. The databases also allow for the identification and comparison, by demographic and clinical characteristics, of eligible women who were "reached" and women who were "not reached" by the intervention. The study has the advantage of the perinatal period being an opportune "teachable moment," and has the support of KP clinicians and of the KP Regional Perinatal Service Center (Appendix 2). The Center, which has been in operation since 1995, uses the telephone to provide medical care for women with GDM during pregnancy. We propose to extend the care delivered by the Center to the postpartum period via telephone counseling on diet, PA and weight reduction. The Center will examine our evaluation of the intervention for possible adoption. The Center's long experience suggests that the proposed intervention, if adopted, has a high likelihood of being sustainable. Assistance from KP's national Chronic Conditions Management Programs and Health Education Department are additional advantages to the setting. The project enjoys considerable support from several KP programs/divisions, as evidenced by its salary support for program evaluators (Appendix 2). Given the easy identification of this group of high risk women in most clinical settings the multiracial composition of Kaiser population (e.g., 27% are Hispanic and 64% are from minority race groups),25 and the use of a case managed telehealth model to deliver the intervention, the proposed intervention has great potential to be transportable to other clinical settings. Telehealth interventions have been shown to be highly effective means of supporting self-care in a variety of populations with diabetes26,27 and multiple health care systems. Despite their high risk for T2DM, the care received by women with GDM has little continuity and is of poor quality after delivery.28,29 Health system adoption of preventative programs designed to extend health care to the postpartum period may ultimately reduce health disparities in this group of women at high risk for developing diabetes at young age. Finally, since we are able to follow women who are enrolled in the proposed study with our prospective electronic medical records, we are already planning a follow-up study beyond the 5-year period, to evaluate whether women in the intervention group are less likely to develop diabetes than women in the usual care group. This additional information will facilitate the evaluation of the proposed program for possible adoption.